Role of TACC2 in smoking-induced COPD

Project Summary
Chronic obstructive pulmonary disease (COPD) is the third leading cause of death in the United States and is
characterized by irreversible expiratory airflow limitation in response to noxious stimuli (e.g., cigarette smoke).
Emphysema, with destructive enlargement of the airspaces, is an important phenotype of COPD that accounts
for high mortality rates. Accumulating evidence suggest a causative role of DNA damage and lung epithelial cell
apoptosis in emphysema pathogenesis. However, the molecular basis for cigarette smoke-induced DNA damage
and apoptosis remains to be elucidated. Our genomic and functional studies identified TACC2 that encodes a
centrosome-interacting protein as a COPD candidate gene. Our novel preliminary data demonstrate that
smokers with COPD exhibit a marked decrease in TACC2 relative to smokers without COPD. We also observed
that Tacc2-/- compared to Tacc2+/+ mice when exposed to cigarette smoke exhibit emphysematous changes
accompanied by DNA damage. TACC2 knockdown impairs homologous recombination, and augments cigarette
smoke-induced DNA damage and cytotoxicity in immortalized human bronchial epithelial cells (HBEC). Cigarette
smoke significantly reduces TACC2 protein via the ubiquitin-proteasome pathway. Indeed, a proapoptotic,
ubiquitin E3 ligase subunit, termed F box L7 (FBXL7), targets TACC2 for its degradation in cells. Furthermore,
TACC2 is found to associate with ataxia telangiectasia mutated (ATM), a key DNA damage-sensing kinase, and
the association is stimulated by cigarette smoke. These preliminary data led us to an overarching hypothesis
that cigarette smoke induces the ATM-mediated DNA damage response through a TACC2-dependent
mechanism that is impaired in COPD, leading to lung epithelial cell apoptosis and the formation of emphysema.
In Aim 1, we will determine whether TACC2 acts through ATM to control cigarette smoke-induced DNA damage
response and cytotoxicity in lung epithelial cells. In Aim 2, we will determine whether ATM-dependent
phosphorylation of TACC2 promotes its FBXL7-mediated degradation in cigarette smoke-exposed lung epithelial
cells. In Aim 3, we will determine whether increased TACC2 stability protects against cigarette smoke-induced
DNA damage response, lung epithelial cell apoptosis, and emphysema. Completion of the proposed studies will
elucidate the mechanisms of smoking-induced DNA damage accumulation in COPD lungs and will potentially
lead to development of a novel therapeutic approach for this debilitating disease.

Public health relevance
Project Narrative Genomic and functional studies performed by us identified TACC2 as a candidate target involved in chronic obstructive pulmonary disease (COPD) pathogenesis. TACC2 is a microtubule- associated protein involved in centrosome and microtubule organization but its role in COPD has not been previously investigated. We discovered that TACC2 deficiency exacerbates cigarette smoke effects on DNA damage and emphysematous changes in a mouse model. In this application, we will further uncover the role of TACC2 in smoking-induced COPD.